Endothelial cell targeting of factor VIII for hemophilia A

ABSTRACT
Hemophilia A is an X-linked bleeding disorder caused by a deficiency in clotting factor VIII (FVIII). Current adeno-
associated viral (AAV) vector mediated gene therapy approaches for hemophilia A are gene addition approaches
that target the liver using promoter elements that result in expression in hepatocytes. However, liver sinusoidal
endothelial cells (LSEC) are the natural site of FVIII synthesis, whereas other coagulation factors are expressed
in hepatocytes. While AAV delivery of factor IX to hepatocytes for hemophilia B has resulted in stable FIX levels
for >10 years, there have been unexpected observations in hemophilia A studies including a lack of a dose
response with variability among patients and a significant decline in FVIII expression in the in first three years
after AAV delivery. We hypothesize that these unanticipated findings in the clinical studies may be related to
the site of FVIII synthesis. Thus, while significant hurdles have been overcome in gene therapy for hemophilia
A, there remain unexplored opportunities to improve hemophilia patient outcomes. The goal of this proposal is
to target FVIII expression to LSECs and to define the biological consequences of targeting FVIII expression to
LSECs compared to hepatocytes. An LSEC targeted genome editing approach (Specific Aim 1) will be compared
to an LSEC targeted AAV gene addition approach (Specific Aim 2) using novel tools that we have developed—
an engineered AAV capsid with improved LSEC targeting and a lipid nanoparticle conjugated to PECAM-1 that
targets endothelial cells. Targeting expression to LSECs or hepatocytes using an AAV approach compared to
a genome editing strategy will provide the opportunity to define of the biological differences of expressing FVIII
in LSECs compared to hepatocytes (Specific Aim 2). The study of whether chronic liver disease or acute liver
injury may affect FVIII expression and different cell types after gene delivery using a genome editing or gene
addition approach will also be investigated (Specific Aim 3). Together, these studies will provide the basis for
understanding the biology and efficacy of LSEC targeted FVIII expression to support the development of
approaches to target FVIII to its endogenous site to overcome the challenges of hemophilia A gene therapy.

Public health relevance
PROJECT NARRATIVE Gene therapy for hemophilia A aims to provide long term expression of clotting factor VIII to correct the bleeding disorder. While the natural site of factor VIII synthesis is the liver sinusoidal endothelial cell, current adeno- associated viral vector delivery approaches target expression to hepatocytes. The goal of this study is to use a genome editing or a gene addition approach to target liver sinusoidal endothelial cells to achieve therapeutic levels of factor VIII and to understand how hepatocyte and endothelial cell specific expression may impact outcomes in gene therapy.